Adaptation of the Friendship Bench mental health intervention for HIV-infected perinatal women in Malawi

ABSTRACT {Abstract remains the same as provided in the parent grant application}
In many sub-Saharan African countries, the scale-up of lifelong antiretroviral treatment (ART) to all
pregnant and breastfeeding women under Option B+ has the potential to radically improve maternal health and
reduce mother-to-child HIV transmission. However, loss to HIV care after delivery has emerged as an
important threat to the hoped-for impact of Option B+. Evidence suggests that one important contributor to
postpartum loss to HIV care is perinatal depression (PND). PND affects up to 43% of HIV-infected women
during pregnancy and 31% of HIV-infected women postpartum. In non-pregnant HIV-infected populations,
depression has been linked to poor ART adherence, reduced engagement in care, and ultimately worse HIV
clinical outcomes. Thus, interventions that integrate PND treatment with targeted support for HIV care retention
are critical to the success of Option B+.
The Friendship Bench is an evidence-based depression counseling intervention delivered by trained,
supervised lay health workers. The Friendship Bench is proven to reduce depression in the general population
in low-resource settings, but has not been adapted to address PND, or enhanced to support engagement in
HIV care. The Friendship Bench is based on problem-solving therapy, which offers an ideal framework for
integrating retention support into a proven depression treatment model. Our long-term goal is to adapt, test,
and scale up resource-appropriate interventions to reduce PND and improve engagement in HIV care. The
objective of this proposal is to lay the groundwork for an effectiveness trial by (1) adapting the Friendship
Bench intervention to address PND and support engagement in care among perinatal HIV-infected women and
(2) assessing the feasibility, acceptability, and fidelity of the adapted intervention. The proposed project will
take place in Lilongwe, Malawi, where Option B+ was first piloted in 2011. In-depth perspectives on PND and
its role in engagement in care will be gathered from HIV-infected women with PND, healthcare providers, clinic
directors, and Ministry of Health officials using qualitative interviews and focus groups. This formative research
will be used to develop an intervention protocol adapted to the unique needs of HIV-infected women during the
perinatal period (Adapted Friendship Bench) and further enhanced to support engagement in HIV care
(Enhanced Friendship Bench). The Adapted and Enhanced Friendship Bench interventions will be compared
to enhanced standard care in a 3-arm pilot study. Feasibility, acceptability, and fidelity will be assessed at 6
months postpartum, along with the interventions’ preliminary effectiveness across several mental health and
engagement in HIV care measures. The proposed aims pave the way for a R01 application to test the adapted
and enhanced Friendship Bench interventions in a cluster randomized controlled trial and represent an
important step forward towards improving PND among HIV-infected women, and ultimately HIV outcomes for
women in the Option B+ program.

Public health relevance
PROJECT NARRATIVE {Project Narrative remains the same as provided in the parent grant application} Perinatal depression affects 30-40% of HIV-infected women during pregnancy and the postpartum period, is rarely treated, and likely leads to suboptimal engagement in HIV care. The proposed project addresses the overwhelming burden and negative consequences of perinatal depression by adapting an evidence-based counseling intervention to the unique needs of HIV-infected women, and further enhancing it to support engagement in HIV care. Addressing perinatal depression and its influence on engagement in care through an integrated counseling intervention is expected lead to improved mental health, HIV care engagement, and ultimately better clinical outcomes for HIV-infected women.